Development of Wave 2 of the Well Being Module of the American Time Use Survey.

This IAA will provide funds for the development and fielding of the second wave of the Well Being Module of the American Time Use Survey, an ongoing nationally representative survey undertaken by the [unreadable]Bureau of Labor Statistics.